"Core A" Administrative Core

Summary
The Administrative Core supports productive interactions between the different projects and cores, and facilitates
communication and data exchange between all associated personnel and the external advisory board (EAB).
The Administrative Core monitors the progress of each project, and the effective utilization of service core
resources. Importantly, the core will provide fiscal management, ensuring that all funds are utilized efficiently to
support the Program Project’s mission. A key core activity is to organize an annual review by the EAB, in the
context of a Program Project retreat, where project leaders and trainees will report on scientific progress. This
event will complement the monthly project leader meetings, and will foster integrated scientific interactions
between scientists working in the project leaders’ laboratories and core facilities. In addition, the core will facilitate
training sessions, enabling trainees at Tulane to receive training at UF in Recombinant Viral Genetics (Core C),
and to provide hands-on bioinformatics training at Tulane (Core B) for UF trainees. We note that travel costs for
these training-specific activities will be provided as institutional support by the University of Florida. Core A will
support the timely publication of findings from the P01 components. Finally, the core will securely archive
research data, share data between groups, and disseminate results with the scientific community after
publication. To facilitate these goals, the core maintains a Program Project-specific website in close coordination
with Cores B, C, and D and Projects 1, 2 and 3.

Public health relevance
Narrative The Administrative Core provides financial and administrative oversight, and facilitates communication between the program projects and service cores. As such, the core plays a key role in the success of the program, which is focused on understanding how viral and host long noncoding RNAs contribute to herpesvirus-associated disease and cancer.